Pediatric and Adolescent Gynecology Training Program

The NICHD Fellowship in Pediatric and Adolescent Gynecology (PAG) is comprised of faculty from three institutions: The National Institute of Child Health and Human Development (NICHD), MedStar Washington Hospital Center (MWHC) and Childrens National Health System (CNHS). Previously housed at MedStar Washington Hospital Center, the Pediatric and Adolescent Gynecology Fellowship has been training fellows since 2010 with the mission to ensure the graduate possesses the knowledge, skills, and professional attributes essential to be able to function as a consultant to pediatricians, family practitioners, obstetricians and gynecologists for girls from birth up to age 18-21 years with pediatric gynecologic concerns as well as older women born with congenital anomalies. Pediatric and Adolescent Gynecology is closely related to Reproductive Endocrinology and thus this program will be synergistic with the existing Fellowship in Reproductive Endocrinology and Infertility.